Improving cancer family history collection through social networking and artificial intelligence

PROJECT SUMMARY The activities proposed in this NCI K07 application are designed to advance the career development and research independence of Dr. Brandon M. Welch. Family health history (FHx) is one of the most important resources available to help clinicians identify disease risks. By knowing a patient's FHx, clinicians can quickly identify disease risks and initiate risk-reducing strategies such as increased screening, prophylactic surgery, risk-reducing therapeutics, and lifestyle changes. FHx is also the foundation of genomic medicine. Unfortunately, the collection and use of FHx by patients and clinicians is suboptimal. To improve the collection and use of FHx among the general population, a better FHx tool that is easier and more convenient to use than current FHx tools is needed. A new FHx web tool, called “ItRunsInMyFamily.com,” incorporates artificial intelligence and social networking to improve user engagement with FHx collection.Utilizing artificial intelligence based chat entity can improve the collection of FHx information by making it easier and more engaging to record FHx information, likewise social networking allows users to tap into the collective wisdom and knowledge of the family to correct inaccuracies and overcome gaps in FHx knowledge. This research study will first identify enhancements to “ItRunsInMyFamily.com ”that will further promote user engagement, with particular focus on rural and underserved patients (Aim 1). We will then evaluate whether this new FHx tool can improve collection of cancer FHx in comparison with current FHx tools (Aim 2). Finally, we will assess the impact of “ItRunsInMyFamily.com ”on the clinical settings (Aim 3). To implement the research plan, it will be critical to apply, skills obtained through K award learning objectives, namely clinical oncology (learning objective 1), iterative patient-centered design (learning objective 2), and health technology assessment (learning objective 3). To fulfill these learning objectives, an interdisciplinary group of mentors will direct a comprehensive training plan. The training plan includes coursework, seminars, workshops, journal clubs, and conferences, covering clinical oncology, patient engagement, health disparities, user-centered development, human-computer interaction, clinical research methodologies, health technology assessment, and ethical conduct of research. The strong support of an excellent team of mentors, and the vast resources of the Medical University of South Carolina, create an optimal training environment. Collectively, the integrated learning objectives and research plan are critical to establishing a successful, innovative, and meaningful academic career focused on developing patient-centric informatics tools for oncology.

Public health relevance
PROJECT NARRATIVE Family health history (FHx) is one of the most important risk factors for cancer and the foundation of genomic medicine, but is under-utilized by patients and clinicians. By incorporating artificial intelligence and social networking into a FHx tool, it will lead to greater engagement with FHx collection. This research study will identify and incorporate features that promote user adoption, and evaluate its impact on FHx collection.